Optimal timing of prehospital advanced airway management and epinephrine administration for out-of-hospital cardiac arrest

ABSTRACT
The overarching goal of this R21 Grant proposal is to identify the optimal timing of prehospital advance life
support (ALS) interventions for patients with out-of-hospital cardiac arrest (OHCA). The ALS interventions
include advanced airway management (AAM: i.e., endotracheal intubation and supraglottic airway placement)
and epinephrine administration. OHCA is a major public health problem worldwide, annually affecting over
356,000 Americans with substantially high rates of mortality and functional disability. Emergency medical
services (EMS) play an important role for patients with OHCA by providing initial prehospital care, including the
ALS interventions in the field. However, the optimal timing of the ALS interventions remains unclear. The 2019
International Liaison Committee on Resuscitation (ILCOR) Summary Statement, International Consensus on
Cardiopulmonary Resuscitation and Emergency Cardiovascular Care Science With Treatment
Recommendations identified the optimal time of both AAM and epinephrine administration as key knowledge
gaps. We recently found that, for adults with both shockable and nonshockable rhythms, benefit of epinephrine
decreased as the administration was delayed, using the Resuscitation Outcomes Consortium (ROC) registry, a
large multicenter OHCA registry in the United States and Canada. This R21 Grant project proposes to further
expand our research into AAM and pediatric population, analyzing the ROC data. Specific research Aims
include identifying the optimal timing of AAM (Aim 1A) and endotracheal intubation (Aim 1B) for adult patients
with OHCA, the optimal timing of AAM (Aim 2A) and endotracheal intubation (Aim 2B) for pediatric patients
with OHCA, and the optimal timing of epinephrine (Aim3) for pediatric patients with OHCA. This R21 Grant
application will provide the Principal Investigator (PI) with protected time to achieve research aims to improve
outcomes for patients with OHCA. The results of this R21 proposal will provide crucial information on the timing
of ALS interventions for OHCA and inform future national and international resuscitation guidelines.

Public health relevance
PROJECT NARRATIVE Annually, over 356,000 Americans have cardia arrest at outside of hospitals, and emergency medical services (EMS) provides crucial care such as airway management and medication administration. However, the optimal timing of these EMS resuscitation interventions remains unclear. This proposal will identify the optimal timing of the resuscitation interventions at EMS systems that impacts survival after out-of-hospital cardiac arrest.